Comparing a low-cost, hand-held icterometer to transcutaneous and serum measurement of neonatal bilirubin among dark-skinned infants: Can jaundice screening be improved in low-resource settings?

Abstract
Neonatal jaundice remains a challenge globally, contributing to significant newborn morbidity and mortality in
low- and middle-income countries. This proposal, “Comparing a low-cost, hand-held icterometer to
transcutaneous and serum measurement of neonatal bilirubin among dark-skinned infants: Can jaundice
screening be improved in low-resource settings?” builds on previous validation research of the Bili-RulerTM, a
hand-held icterometer developed at Harvard University. The Bili-Ruler has 6 digitally standardized strips of
increasingly yellow hue that allow for comparison against blanched newborn skin. Previous research
demonstrated acceptable diagnostic testing metrics in measuring elevated bilirubin, yet data are limited by a
small sample size in patients of African descent, raising questions as to how effective the Bili-Ruler is among
dark-skinned infants. We propose to conduct a robust validation study among newborns in Kumasi, Ghana, in
West Africa (where 99% of the population is from one of 10 African ethnic groups) to address this gap in
understanding. We aim to test the Bili-Ruler against both transcutaneous (TCB) and serum (TSB) bilirubin
measurements among Ghanaian newborns to determine if this low-cost, hand-held device is a viable option to
improve jaundice screening and monitoring in sub-Saharan Africa. Our study includes the following aims:
Aim 1: To determine screening accuracy of the Bili-Ruler, we will compare healthcare providers’ Bili-
Ruler assessments with measures of TCB on 2000 newborns and TSB on 400 newborns. We will use
gestational age at birth, hours since birth, and risk factors for jaundice to determine if TCB and TSB
levels are above the recommended threshold for treatment, and we will compare findings against
newborns judged to have Bili-Ruler scores of 3 or higher. We will calculate sensitivity, specificity,
positive predictive value (PPV), negative predictive value (NPV), and area under the curve (AUC) for
the Bili-Ruler against TCB and TSB.
Aim 2: To determine differences in the Bili-Ruler’s accuracy based on both underlying skin tone and
severity of jaundice, we will use scores on the Monk Skin Tone Scale (range: 1-10) and increasing
thresholds on the Bili-Ruler (e.g. 3+, 4+, 5+) to explore differences in sensitivity, specificity, PPV, NPV
and AUC for the Bili-Ruler against TCB and TSB, using healthcare providers’ assessments.
Aim 3: To determine inter-rater reliability, we will compare healthcare providers’, researchers’ and
mothers’ scores on the Bili-Ruler using correlation, Kappa, and McNemar’s statistical tests.
This research is innovative in that it seeks to determine whether a simple, low-tech, hand-held “ruler” could be
used as a valid screening tool for neonatal jaundice. If so, the implications for jaundice screening in low-
resource settings is significant, given that screening could then be conducted at lower-level facilities
or in remote communities without access to TCB and TSB assessments.

Public health relevance
Project Narrative The goal of this research is to determine whether a low-cost, low-tech, hand-held icterometer could serve as a screening tool for neonatal jaundice in settings lacking a transcutaneous bilirubin meter or the capacity for serum bilirubin assessment. This R21 seeks to determine the validity of the Bili-RulerTM among newborns in Kumasi, Ghana, when compared to transcutaneous and serum bilirubin measurement, as well as determine the impact of underlying skin tone, severity of jaundice, and reliability across healthcare providers, researchers, and mothers. If successful, the findings of this research could expand opportunities for neonatal jaundice screening and monitoring in low-resource settings, thereby improving early detection and treatment and, ultimately, newborn outcomes.